THE IMMUNOLOGY DATABASE AND ANALYSIS PORTAL (IMMPORT)

This contract provides critical bioinformatics support to DAIT-funded biodefense immunology research through the continuation and refinement of ImmPort, and continued development of optimal methods for data collection, storage, exchange, and interoperability; development and implementation of novel data integration and retrieval methods; enhancement of capabilities for clinical data access and support, provision of technical user support; and optimization of user value through provision of multiple workspace levels and analytic tools.
ImmPort is one of the largest open repositories of subject-level human immunology data, with a commitment to promoting effective data sharing across the basic, clinical, and translational research communities. ImmPort collects data both from clinical and mechanistic studies on human subjects and from immunology studies on model organisms; it has an indispensable role in meeting the research needs and NIH data-sharing mandate. ImmPort archives data from large-scale clinical trials, supports over 45 specialized data types, and enables participant-level data sharing and mechanistic data, promoting hypothesis generation and innovation.
In addition, this contract includes options to develop novel analysis tools and provide information technology infrastructure for production, pilot, and quality assurance environments. This contract is for services to provide critical bioinformatics support to DAIT-funded biodefense immunology research.